Human Tissue Repository and Tissue Analysis

Project Summary/Abstract - Human Tissue Repository & Tissue Analysis Shared Resource The UNMCCC Human Tissue Repository and Tissue Analysis Shared Resource (HTR Tissue), supports basic and translational cancer research by providing cost effective tumor and matched normal tissue either as frozen or Formalin-Fixed, Paraffin-Embedded (FFPE) aliquots to UNMCCC members and non-member users. Scientific Director Dennis J. McCance, Ph.D. (CT) supervises the Resource, which is operated by a full-time staff including experienced wet lab research technicians plus a digital imaging expert providing services aligned with the College of American Pathologist (CAP) Accreditation Program. The UNMCCC and the UNM HSC Department of Pathology jointly manage the Resource, which provides several essential services including sectioning, H&E, immunohistochemical or immunofluorescence staining of tissue sections and digital imaging and annotation of stained specimens. The Resource currently houses > 40,000 biospecimens, with >20,000 frozen and >13,000 FFPE biospecimens and >6,000 blood samples (whole blood, serum, plasma and both frozen and cryo-preserved cells) that reflect the race/ethnicity of our population in New Mexico with 36% of the samples from Hispanic, 49% from non-Hispanic white and 12% from Native American and 3% other race/ethnicities. During the last grant period we dispensed 1,196 tissue specimens, 1,496 slides for DNA/RNA extraction and processed 4,000 animal tissues. As the Cancer Center has developed its precision medicine initiative and joined the ORIEN consortium, HTR Tissue has expanded the tissue collection to include blood and/or saliva from all consented patients (germline control), and blood and bone marrow from patients with hematological malignancies (New Services). The Resource maintains a database of the collected tissues (TissueMetrix) with critical information on the patient (e.g. name, date of birth and race/ethnicity), tissue source and diagnosis, and other variables including the method of tissue collection, ischemic times, and how the tissue was processed after receipt by the HTR Tissue. Projects, billing and usage are tracked through a centralized on- line system. The Resource Director and staff work closely with the Research Programs to develop new methodologies that promote innovative basic and translational research goals and the Resource actively facilitates and disseminates information about new imaging and annotation technologies by maintaining an up- to-date web page and by giving presentations at UNMCCC meetings and retreats. During the previous 5-year project period, 101 investigators, of whom 59 were UNMCCC members from all 3 UNMCCC Research Programs, used the Resource. The Resource contributed to 38 cancer focused publications by the UNMCCC users, who were supported by 120 peer-reviewed grants. In the reporting year of July 2019 – June 2020, the CCSG supported 17% of the Resource budget with UNMCCC members responsible for 74% of Resource usage.